FQHC Intervention for CGM Uptake in Hispanic Adults with T1D

Abstract
Low-income Hispanic adults with type 1 diabetes (T1D) experience a disproportionate burden of life-threatening,
acute complications, both hypoglycemia and diabetes ketoacidosis, with high rates of related emergency
department visits, hospitalizations, and death. Use of continuous glucose monitoring (CGM) may mitigate these
inequities. Yet, Hispanics with T1D have exceptionally low levels of CGM use. This reflects social determinants
of health (SODH), as framed by the multiple levels of the Socio-Ecological Model (SEM). The SEM’s healthcare
provider level is a main driver in Hispanic disenfranchisement from CGM. With a severe shortage of
endocrinologists, primary care providers are increasingly managing T1D although a high majority report
inadequate confidence in titrating insulin and using CGM. With limited access to endocrinology, low-income,
Hispanic adults with T1D thus often receive diabetes management in federally qualified health centers (FQHCs)
with scant or no access to CGM. Hence, to foster equitable uptake of CGM in the most vulnerable Hispanic
adults with T1D, a 4-year, mixed-methods, feasibility study with a pilot randomized controlled trial (RCT) is
proposed to primarily assess the feasibility of the SEM-guided intervention (targeting the individual, family/social
networks, and healthcare provider levels). The individual level of the intervention fosters essential acquisition of
information, motivation, and behavioral skills for CGM uptake through two approaches: (1) 4-week, personalized,
CGM sessions with a RN certified in diabetes education; and (2) followed by peer education visits between data
collection points. The family/social networks level leverages the core Hispanic values of familismo and
collectivismo to promote critical support in CGM uptake with a family member co-attending the 4-week sessions
and participant engagement with a peer educator during scheduled visits, respectively. The provider level of the
intervention is designed to promote enhanced cultural competency in intervention delivery and provide clinical
support for CGM informed by rigorous training in T1D management and CGM via Project ECHO. In study phase
1 (Aim 1), the intervention, informed by stakeholder qualitative findings, will be refined and RCT deployment will
be planned with 4 FQHC sites randomized to deliver the intervention (n=2) or control (n=2) conditions with a total
enrollment goal of 30 Hispanics with T1D (sites having roughly equivalent enrollment rates). Project ECHO: CGM
& T1D Care will also be delivered to intervention site providers. In phase 2 (Aim 2), the feasibility of the study
protocol (e.g., recruitment and retention yields, data collection procedures, intervention implementation, and
intervention acceptability, among others) will be routinely assessed. In phase 2 (Aim 3), significant intervention
signals in terms of physiological (e.g., A1C and time within, above, and below range), psychosocial (e.g., quality
of life, family support, physician trust), and behavioral (CGM adherence) outcomes from baseline to 3- and 6-
months postbaseline will be assessed. The long-term goal of this study is to inform a large, multi-site RCT, and
with successful results, provide a model for CGM uptake in Hispanic adults with T1D for FQHCs nationally

Public health relevance
Project Narrative Hispanics adults with type 1 diabetes (T1D), despite their disproportionate burden of acute complications (hypoglycemia and diabetes ketoacidosis) and related emergency department visits, hospitalizations, and death, remain largely disenfranchised from continuous glucose monitoring (CGM), an efficacious technology to mitigate these inequities. To increase CGM uptake in low-income, Hispanic adults with T1D receiving diabetes management in federally qualified health centers (FQHCs), the proposed mixed-methods study, with a pilot randomized control trial (RCT), will assess the feasibility of our study protocol, including our multi-level intervention informed by the Socio-Ecological Model. If the proposed multi-level intervention is found to be feasible and RCT findings indicate the intervention, relative to the control condition, shows promise, we anticipate a large-scale, multi-site RCT to follow to provide rigorous evidence in favor of our CGM intervention model to improve T1D outcomes in vulnerable Hispanic adults receiving diabetes care in FQHCs.